DEVELOP AND IMPLEMENT CAPACITY FOR EXPANDED HISTOTECHNOLOGY EFFORTS

The Division of Cancer Treatment and Diagnosis (DCTD) will expand its pathology effort and build out additional capacity so that additional activities can be addressed in order to support in vivo evaluation xenograft efforts and clinical pharmacodynamics biomarker efforts. The specific expansion will focus on the development and implementation of SOPs for tissue processing, sectioning, staining and image capture of tumor specimens, as well as to analytically validate selected IHC or IFA assays in the CLIA environment for patient selection in support of DCTD clinical trials.